HLA LOH Detection via Liquid Biopsy: A Blood-Based Predictive Biomarker Assay for Precision Immuno-Oncology

PROJECT SUMMARY/ABSTRACT
T-cell-receptor (TCR)-mediated immunotherapy, including immune checkpoint inhibitor (ICI) therapy, is becoming
a mainstream cancer treatment modality, but the majority of patients still do not respond to these therapies.
Human leukocyte antigen class I loss of heterozygosity (HLA LOH) is a mechanism of resistance to TCR-
mediated immunotherapies and is found in the tumors of 1/6 of all cancer patients. In some cancer types the
prevalence of HLA LOH is higher, and in non-small-cell lung cancer (NSCLC), approximately 40% of patients
have tumors that harbor HLA LOH. To improve immunotherapy treatment outcomes for NSCLC patients, it is
crucial to utilize a diagnostic assay to detect whether a patient’s cancer has HLA LOH. Tempus offers an assay
that detects HLA LOH in cancer patients using a tumor-based approach which received FDA Breakthrough
Device Designation and is now utilized for patient enrollment screening in two clinical trials. However, a tumor-
based assay requires surgical biopsy, which is not always feasible. A blood-based liquid biopsy for detecting HLA
LOH in patients with solid malignancies would allow for detecting the biomarker without the need for collecting a
tumor biopsy sample, but there is no commercial HLA LOH liquid biopsy assay for solid malignancies on the
market. Our startup, Sesh, is commercializing the first liquid biopsy assay for detecting HLA LOH in cancer
patients with solid tumors. Sesh’s liquid biopsy assay, RELOAD (Restriction Element Loss Of Allele Detection),
is a cell-free DNA (cfDNA) next-generation sequencing (NGS) assay co-invented by our CEO Dr. Andrew Sinkoe
while he was a postdoctoral fellow at the National Cancer Institute (NCI) Center for Immuno-Oncology. Sesh has
licensed the liquid biopsy technology underlying RELOAD from the NCI Technology Transfer Center (TTC) via a
Commercial Evaluation License (CEL) and is applying for a Phase I SBIR-TT to continue the commercialization
process for the technology. Sesh plans to conduct concordance studies and analytical validation studies that will
lead to the assay’s usage in the clinic, and our goal is to eventually obtain FDA approval for the assay via a PMA
to bring RELOAD to market. This SBIR-TT Phase I focuses on implementing RELOAD in NSCLC as this cancer
type has a high prevalence of HLA LOH and patients with this type of cancer have been shown to have
significantly worse responses to ICI therapy when harboring HLA LOH compared to patients with HLA intact.

Public health relevance
PROJECT NARRATIVE Human leukocyte antigen class I loss of heterozygosity (HLA LOH) is a difficult biomarker to assess via genomic analysis due to the large number of single nucleotide polymorphisms (SNPs) in the HLA class I genes, HLA-A, HLA-B, and HLA-C. In fact, there are over 20,000 HLA class I alleles in the human population. Despite the difficulty, it is crucial to have the capability to detect HLA LOH in cancer patients because this biomarker is a cause of resistance to T-cell-receptor (TCR)-mediated therapies such as immune checkpoint inhibitors in a substantial proportion of patients. Furthermore, two new adoptive cell therapies currently in clinical trials require knowledge of each patient’s HLA LOH status prior to enrollment, thus ushering in a new era where HLA LOH testing will be required for clinical trial enrollment and treatment decisions. One cell therapy in trials for all solid tumors is designed specifically for patients whose tumors harbor HLA LOH. Our company, Sesh Incorporated, is commercializing the first liquid biopsy assay to detect HLA LOH in cancer patients with solid malignancies. The assay was invented by our CEO while a postdoctoral fellow at the National Cancer Institute (NCI), and the proof- of-concept data utilizing the assay led the NCI Technology Transfer Center (TTC) to file a provisional patent, followed by a PCT international patent, followed by a National-Stage patent in the U.S. and Europe for the technology. Sesh has completed a Commercial Evaluation License (CEL) agreement with NCI and is applying for a Phase I SBIR-TT to continue the commercialization process for the assay. Sesh collaborates with NCI and Frederick National Laboratory for Cancer Research (FNLCR) on studies to evaluate concordance and analytical performance of the assay. Sesh’s liquid biopsy for HLA LOH detection offers advantages over tumor-based solid biopsies, and will be an important tool for determining individualized treatment courses for cancer patients.